EFFECT OF DIURETICS ON RESTING ENERGY METABOLISM IN WOMEN

The purpose of this study is to examine the effects of diuretic induced dehydration on resting metabolic rate and substrate utilization as indicated by respiratory quotient.